Cell Morphology-guided, Scalable and Controllable Molecule Design via Generative AI

Project Summary
This project aims to advance phenotypic drug discovery (PDD) by developing a generative AI-driven platform for
innovative, cell morphology-guided, scalable, and controllable small molecule design without relying on drug
targets. By integrating tri-modal contrastive learning, controllable morphology generation, and retrieval-
augmented molecule design, the platform addresses key PDD challenges, including limited understanding of
structure–morphology relationships, inconclusive data generation, and lack of explainability in molecule design.
Aim 1 will establish relationships among molecular structures, induced morphological changes, and textual
descriptions to create a unified representation space. Aim 2 will develop a scalable and controllable diffusion
model to generate morphology images that accurately reflect biological responses to chemical treatments. Aim
3 will implement a retrieval-augmented platform for traceable de novo small molecule design, leveraging external
data sources to enhance explainability. This project will enable a target-agnostic approach to drug design,
expanding therapeutic options for diseases without identified drug targets.

Public health relevance
Project Narrative Phenotypic drug discovery (PDD) offers a promising approach for developing first-in-class drugs for diseases without identified targets. However, existing generative AI methods are limited due to lacking a deep understanding of structure-morphology relationships, inconclusive data generation, and limited explainability for molecule design, restricting their potential applications in PDD. This project proposes a novel generative AI platform, integrating tri-modal contrastive learning, controllable diffusion modeling, and retrieval-augmented generation, to facilitate scalable and explainable molecule design, advancing PDD for a wider range of diseases.